Integrin-Targeted Novel Oral Therapeutics for Lupus Nephritis

Project Summary
Lupus nephritis (LN) remains the strongest predictor of morbidity and mortality for people with Systemic
Lupus Erythematosus (SLE), an autoimmune disease disproportionately affecting women and minorities. The
current standard of care for LN, glucocorticoids and immunosuppressive agents, has many side effects and
long-term toxicity. Therefore, there is an urgent and unmet need for targeted therapies. SLE is characterized by
an aberrant activation of toll-like receptor (TLR) signaling in immune cells that drives inflammatory leukocyte
activation and influx into major organs, with approx. 40% of lupus patients showing glomerular injury and renal
disease, LN. The integrin CD11b, expressed primarily on myeloid cells, is an immune receptor that modulates
functions of these cells. Among its many roles, it mediates leukocyte influx in tissues and has recently been
shown to also control overactive TLR signaling in these cells. Recent GWAS studies showed high correlation
between patients with SNPs in ITGAM, which codes for CD11b, and incidence of SLE and LN. Studies also
showed that the three most common coding ITGAM SNPs primarily reduce CD11b’s role as a rheostat of TLR-
signaling, without affecting its surface expression, suggesting reduced CD11b function as a contributor to SLE
and LN. It also suggested that CD11b activation could serve as a potential therapeutic strategy for LN. Towards
that, our co-founder (Vineet Gupta) discovered that allosteric activation of integrin CD11b is a novel therapeutic
strategy and is an effective method to target this integrin for reducing leukocyte activation and tissue influx. He
and his team developed a first-generation CD11b small molecule allosteric agonist, called LA1, that selectively
engages CD11b in vivo, is orally bioavailable, non-toxic, reduces autoimmune disease and significantly reduces
influx of inflammatory myeloid cells into tissues. Drs Gupta, Barbosa and the team also developed an LA1
analog, called GB1275, that has been translated as an oral therapeutic that is currently under Phase 1/2 clinical
trials in cancer patients. The primary goal of this proposal is to find and develop a new series of allosteric
agonists of CD11b with tractable SAR, drug-like properties and with enhanced potency over the first-generation
compounds that can be administered chronically for treating autoimmune diseases, like LN. We have developed
an assay platform and a focused integrin targeting library of ~800 compounds that can be used to rapidly identify
and develop novel, highly potent CD11b agonist candidates with high confidence. Here, we propose two specific
aims to design, screen and identify novel CD11b agonists with improved potency over LA1 and to characterize
them in vitro and in vivo for their readiness for drug development. Our long-term goal is to develop the new
compounds into a next generation of therapeutics to treat lupus nephritis in humans.

Public health relevance
The studies proposed will use medicinal chemistry approaches to design, test and develop novel small molecule compounds as future therapeutics for lupus nephritis. The company is pioneering a novel therapeutic approach and has developed a suite of assays and unique library of compounds that show drug-like properties with high potential for clinical development.